SWG 5: Curative Therapies for HIV

Abstract
The mission of the Curative Therapies for HIV Scientific Working Group (SWG) is to encourage the
development of a cure for HIV, by fostering new ideas and promoting new technology. During the previous
funding cycle this continuing SWG was highly successful in its efforts to bring together local researchers and
community members with the aim of advancing cure research. As the HIV pandemic continues to affect many
millions of lives globally, there is still an urgent need for an HIV cure, so we will continue to support research
into curative therapies through our SWG. The long-term objective of our SWG is to stimulate novel research,
which can progress into a cure for HIV that can ultimately be transitioned into the clinic, and reduce the global
burden of HIV that remains. To achieve our mission the SWG will continue to bring together UW/Fred Hutch
CFAR affiliated researchers, unaffiliated external HIV researchers, and community members, through a series
of scientific networking events, forums and an annual conference, each with a defined purpose. The goals of
this SWG will be attained through two specific aims that are intended to: 1) Provide infrastructure that fosters
the exchange of new actionable ideas, engages the community, and promotes the development of novel
curative treatments for HIV, and 2) Develop new intra-/inter-CFAR projects and funding applications on
curative therapies for HIV.
Cooperation between researchers and community members from local, national and international settings who
are invested in the common goal of HIV cure will be key to the success of our mission. We plan to leverage
recent NIH investment in the Seattle-led consortium defeatHIV, one of six Martin Delaney Collaboratories
focused on the cure of HIV. We will work with UW/Fred Hutch CFAR cores and external researchers to exploit
expertise across many areas, in order to develop novel research questions and subsequent grant applications
for the study of curative therapies for HIV. We will also work closely with local, national, and international
community members to learn what an HIV cure would mean to them, and to gain new perspectives into how an
HIV cure can be realized. Collaboration is essential to our mission, and by working with people of broad
experience and from diverse backgrounds we hope to serve as an internationally-recognized center for the
study of curative therapies for HIV.